Pathogenesis of Vascular Anomalies with GNAQ mutations

PROJECT SUMMARY/ ABSTRACT:
Hyperactive, postzygotic mutations in the GNAQ gene (encoding for Gaq proteins) have been identified in
vascular anomalies. Patients affected by this class of vascular anomalies experience extensive disfigurement
and can develop a life-threatening coagulopathy termed Kasabach-Merritt Phenomenon (KMP). Despite these
genetic findings, animal models for GNAQ-related vascular anomalies and KMP do not exist. This has severely
hindered the preclinical development of effective targeted therapies for these patients.
In our preliminary experiments we generated a transgenic murine model of mutant hyperactive GNAQ-driven
vascular anomaly which recapitulates common histopathological findings in patients and a coagulopathy
reminiscent of KMP, a potentially lethal disease complication. Furthermore, our studies showed that in patient-
derived lesional tissue with GNAQ Q209L mutation, the MAPK/ERK signaling pathway is hyperactive as well as
increased EC proliferation. We have exciting data that the MEK/ERK inhibitor Trametinib extended the life span
of GNAQ mutant mice suggesting this may be a promising therapy for patients.
To date there are no studies examining the role of mutant active GNAQ (p.Q209L) in vascular development and
disease. This proposal will culminate with the development of innovative in vivo, in vitro, and Vessel-on-Chip
models that we will use for the identification of cellular and molecular mechanisms implicated in vascular disease.
Furthermore, with our powerful murine model we are uniquely positioned to develop a comprehensive research
program to investigate the GNAQ role in vascular lesion formation and expansion with the goal of identifying
highly needed therapeutic targets for vascular anomalies and related complications such as coagulopathies.
Additionally, our studies will provide cellular and mechanistic insights to advance our understanding of
pathological and physiological vessel formation and size maintenance.

Public health relevance
TITLE: Pathogenesis of Vascular Anomalies with GNAQ mutations. PROJECT NARRATIVE: A class of disfiguring and life-threatening vascular anomalies is associated with mutations in the GNAQ gene that cause excessive, uncontrolled activity of the protein encoded by this gene. A key roadblock to finding effective, non-invasive treatments has been the lack of animal models for the study of disease development and treatment. Our project goals are to devise a murine model to study vascular disease progression and complications in response to GNAQ activating mutation, and to identify targeted treatments for patients.